The effect of aging on neurotransmitters and motor performance in a primate model

Project Summary
The aging brain undergoes fluctuations in neurotransmitters and gene expression, volumetric atrophy, cellular
senescence, vascular dysfunction, neuroinflammation, and cognitive deficits. Age also is a risk factor for
developing neurodegenerative disorders like Alzheimer's (AD) and Parkinson's diseases (PD). The current
primary therapies for AD and PD target transmission of neurotransmitters acetylcholine and dopamine, and
neurotransmitter deficiencies are associated with cognitive and motor impairments. Thus, investigating species
differences in neurotransmitters is vital to developing effective models of age-related neurological disorders.
Nonhuman primates, particularly chimpanzees, are an invaluable resource for aging studies. Like humans, older
apes experience mild decline in memory, executive function, and cognitive flexibility, and their brains bear
remarkable similarities to elderly humans in gene expression, cerebrovascular dysfunction, and
neuroinflammation. Chimpanzees also exhibit the AD hallmarks of amyloid-beta plaques and neurofibrillary
tangles in the absence of significant neuronal loss or dementia symptoms. One possibility for the lack of severe
cognitive decline in chimpanzees, despite the presence of AD lesions, may be species-specific alterations in
neurotransmitters. While prior studies report mild age-related cholinergic and dopaminergic reductions in aged
macaque brains, the effect of aging and AD pathology on neurotransmitters in chimpanzees remains unknown.
To address this issue, we will investigate neurotransmitter gene expression and protein levels in the chimpanzee
brain for age-, sex- and AD pathology-related changes as observed in humans. Utilizing immunohistochemistry,
unbiased stereology, and postmortem brain samples from adult and aged chimpanzees previously identified with
AD pathology, we will measure neurotransmitter neuron or axon length densities for: dopamine in the dorsal
striatum and midbrain; acetylcholine in the dorsal striatum, basal forebrain, and pons; serotonin in the raphe
nucleus; and norepinephrine in the locus coeruleus. We also will examine expression of genes involved in the
transmission and metabolism of neurotransmitters using bulk RNA sequencing and frozen brain specimens from
young and aged chimpanzees with and without AD pathology. To determine if modifications in neurotransmitters
correlate with behavioral changes, we will use archival behavioral data. In addition, we will assess longitudinal
changes in cognitive functions using an automated touchscreen testing system, motor skill on a tool use task,
walking speed, and agonistic and affiliative social interactions in a cohort of living chimpanzees. Distinguishing
if species differences in neurotransmitter systems are associated with age-related behavioral changes is
essential for improving current models of neurodegenerative and psychiatric disorders, and this proposal will fill
a critical gap in our evolutionary knowledge of the influence of aging and AD neuropathology on
neurotransmitters in chimpanzees, our closest living ancestor.

Public health relevance
Project Narrative Significant differences in neurotransmitters have been identified between rodents and humans, and this biological variance may partially explain why medications for neurodegenerative diseases that often show promise during preclinical development in rodent models fail to elicit the same therapeutic effect in humans. The proposed project will greatly improve our knowledge of the impact of age on neurotransmitters and their associated behaviors in chimpanzees, our closest living relative whose brain naturally develops the pathologic hallmarks of Alzheimer's disease. By gaining a better understanding of species-specific alterations in neurotransmitters, we can potentially improve therapeutic efficacy for age-related neurodegenerative disorders.